New therapeutic approaches to identifying molecules for opioid abuse treatment

Project Summary
Collaborations Pharmaceuticals Inc. is a small business focused on developing treatments for difficult to treat
diseases. The ongoing overreliance on opioids for chronic pain despite their poor ability to improve function has
contributed to a significant and alarming epidemic of opioid overdose deaths and addictions in recent years.
Despite the overwhelming addiction crisis, few therapies exist, and with low efficacy. Thus, a critical unmet need
is an effective and safe treatment for opioid abuse disorders. Recent research has suggested that psychedelics
are also capable of reducing drug-dependence, including opioid abuse, and that serious adverse effects are
extremely rare. This drug abuse cessation is linked to the induction of neuritogenesis and increased
neuroplasticity, a hallmark of psychedelics. While the psychedelic experience and neuroplasticity induction
appear interlinked, several analogs of psychedelics have been proposed which induce neuroplasticity and drug-
avoidance while seemingly lacking the psychedelic experience. Although few in number, these analogs have
been named “psychoplastogens” and are promising candidates for treatment of opioid drug abuse. The de-
coupling of the psychedelic experience and neuroplasticity induction is linked to receptor specificity as
psychoplastogens are specific to 5HT2A. Here, we propose to use a combination of generative machine learning
models with our extensive experience of supervised machine models to generate new analogs of psychedelics
that will have improved 5-HT2A specificity, ADME properties, and are easily synthesizable to rapidly expand the
pool of known psychoplastogens, significantly increasing potential therapeutic options for opioid abuse
treatment.

Public health relevance
Narrative Despite the overwhelming opioid addiction crisis, few therapies exist, and with low efficacy. We propose to use a combination of generative machine learning models with our extensive experience of supervised machine learning models and medicinal chemistry to generate new analogs of psychedelics that have improved 5-HT2A specificity, ADME properties, and are easily synthesizable to rapidly expand the pool of known psychoplastogens, significantly increasing potential therapeutic options for opioid abuse treatment.